Pilot and Feasibility Program

SUMMARY
The Pilot/Feasibility (P/F) Program represents a central component of the Columbia University Digestive and
Liver Disease Research Center (CU-DLDRC). Its primary objectives will be the promotion of highly innovative
research and the expansion of digestive disease-related research opportunities to new investigators. The P/F
Program is built on a long history of successful pilot funding and career building of junior PIs within Columbia
University Medical Center (CUIMC). We successfully established this program in 2019 and have funded seven
investigators thus far, who have enjoyed a high rate of success in obtaining NIH or equivalent funding, providing
a >25-fold rate of return. The P/F is led by two directors with outstanding expertise in adult and pediatric digestive
disease research and administration, Drs. Kara Margolis and Dr. Utpal Pajvani. The P/F Program will provide
three grants of $25k each year, two from CU-DLDRCC funds and another from institutional support, that will
enable eligible investigators to explore hypotheses related to one of the two central themes of the CU-DLDRCC,
in order to gather sufficient data to develop research programs and grant applications for peer-reviewed
extramural funding. The P/F awards fund different tracks, in prioritized order. Track 1: New investigators seeking
initial support. Track 2: New or established investigators aiming to pursue innovative high-risk, high-reward
projects in digestive disease. Track 3: Established investigators from other fields who seek to apply their
expertise to research in digestive disease. The P/F Program will be highly synergistic with other translationally
and clinically focused intramural internal funding mechanisms at CUIMC. P/F awardees will enjoy additional
benefits that will substantially promote their research, including Biomedical Core subsidies that go far beyond
the funding duration; integration into our comprehensive academic mentorship program via the Enrichment
Program integration as well as into CU-DLDRC activities in research and education such as clinical-basic teams,
workshops and seminars. The P/F program will contribute to the mission of the CU-DLRDC through three
Specific Aims: To solicit and rigorously peer review applications, thereby supporting highly innovative research
as well as rising stars in digestive research (Aim 1); to maximize the success of P/F-funded researchers through
opportunities for scientific interactions, education, training and mentorship as well as CU-DLDRC core subsidies
(Aim 2); and to provide efficient oversight of P/F program outcomes through long-term tracking of awardees
publications and grants (Aim 3). We anticipate the P/F program to enhance the development of the highly diverse
basic and clinical talent and to promote innovative impactful science beyond the horizon of current digestive
research. These three Aims will be under the goal of increasing Diversity, Equity and Inclusion (DEI), through
collaboration with the Enrichment Program, its DEI delegate and the wide range of DEI resources at Columbia.
We have achieved initial success already, leveraging CU-DLDRC and institutional collaborations and resources.